CLINICAL IMMUNE SURVEY OF THE LONGITUDINAL PROJECT PARTICIPANTS

This project uses participants in the Baltimore Longitudinal Study of Aging (BLSA) to gain insight into the biochemical and molecular mechanisms underlying age-associated changes in human immune function. Recent data suggests that human T lymphocytes activated through different cellular pathways display distinctive patterns of protein phosphorylation, cytokine synthesis and gene expression, only some of which are age-affected. With increasing age, an increasing large proportion of T-cells undergo cytokine-mediated apotosis.